Research Pathology

Abstract Shared Resource 10: Research Pathology (RP-SR)
The overall goal of RP-SR is to provide COHCCC Members with access to high-quality, timely, and cost-effective
pathology services that support a broad range of studies and access to human biorepository collections. RP-SR
comprises the Solid Tumor Biorepository (STB) and Hematopoietic Tissue Biorepository (HTB), Research-
(Histology, Molecular Pathology, & Cytogenetics); and the Research Pathology Informatics (RPI) resource.
Specific Aims for RP-SR:
Aim 1. Provide centralized and standard procurement, processing, storage, annotation, and distribution
of human biospecimens and coordinate specimen collection across the COH Clinical Network.
Aim 2. Provide high quality, cost-effective, and value-added research histology in the specialized areas
of histopathology, hematopathology, immunohistochemistry, and digital pathology and provide
specialized collections and cell enrichment services for COHCCC Members.
Aim 3. Provide tissue-based genomic analysis and cytogenetic services for COHCCC Members.
The Biorepository Services include procurement of tissue, blood/derivatives from patients and volunteers, bone
marrow (BM) aspirates, buccal cells and skin, and stool (for microbiome studies) and normal donor blood
collection protocols. the Biorepository Services collect, de-identify, and process tissues for correlative studies
from patients enrolled in clinical trials. HTB services include cryopreservation of viable mononuclear cells,
immunophenotype-based cell characterization and enrichment, and isolation and expansion of mesenchymal
stem/stromal cells with DNA, RNA, and protein extraction. Specimen tracking is via LabVantage (LV)
management system. Histopathology services include expert interpretation and categorization for solid and liquid
tumors by specialist pathologists and hematopathologists, immunohistochemistry (IHC) validation, multiplex IHC,
and whole slide imaging. The Cytogenetics Laboratory provides cell line characterization, chromosomal
microarray analyses, FISH analyses performed on suspensions, FFPE including tissue microarrays, and frozen
sections. The Research Molecular Pathology Laboratory provides targeted DNA sequencing and data
interpretation, gene expression assays, tissue-based digital spatial profiling, circulating tumor cell isolation ,
digital PCR, and RNA in situ hybridization services. In conjunction with the Honest Broker group, HTB and RP
Informatics provide support for annotation and cohort identification for project requests.
Members Utilization by %Revenue 2017–21: 87.3 Total (11.2 MCBC, 24.4 DCT, 18.5 CI, 27.3 HM, 6 CCPS)
Publications by Members: 211, 72 with Impact Factor >10
Grants Supported: 158 Total (4 ACS, 8 CIRM, 11 DoD, 3 LLS, 71 NCI of 115 NIH (73 R01, 5 U01))
.